Einstein Mount Sinai Diabetes Research Center

TRC abstract
The primary mission of the Translational Research Core (TRC) is to promote high-quality diabetes
translational research, through delivery of services including consultation, technical support, and
training and mentoring in clinical research methods that are specifically applicable to diabetes, its
complications and related metabolic disorders. Core services derive from the broad expertise of Core
investigators, encompassing first-in-human and mechanistic studies in integrative physiology, and
clinical trials involving diabetes and obesity and application of emerging technology, thus spanning a
wide spectrum of translational research. The TRC is strategically focused on clinical physiology and
metabolism and diabetes therapeutics (“T1-T2” research), while maintaining a relationship to the
continuum of translational research at Einstein and its regional partners. The unique strengths of the
TRC in the next project period will position us to promote the continued growth of diabetes-related
translational research at the Albert Einstein College of Medicine (Einstein) and to further integrate
diabetes investigators at the Icahn School of Medicine at Mount Sinai, as well as other regional
partners. Thus, the two key features of the TRC in this renewal are 1) the renewed focus on
early stage translational research (“T1-T2”) and 2) expansion of the Einstein-Mount Sinai DRC
partnership. The TRC provides resources for diabetes research via faculty expertise and
consultation and collaborations with other programs and projects, as well as access to trained TRC
personnel to assist with crucial aspects of human research protocol implementation. In addition, the
TRC leverages resources of the recently renewed Einstein-Montefiore Clinical and Translational
Science Award (CTSA, known as the Institute for Clinical and Translational Research, ICTR) and the
Mount Sinai CTSA’s Institutes for Translational Sciences (“Conduits”), which are key partners in our
efforts to facilitate and promote translational research in diabetes. Both CTSAs provide research
infrastructure and facilitate access to other institutionally sponsored services, while the TRC
specifically focuses on support of the unique needs of investigators in diabetes, obesity and
metabolism and provides direct services beyond the scope of CTSAs. The TRC is designed to
fill critical gaps in the resources needed to promote the broad range of diabetes clinical and
translational research by fulfilling the following Specific Aims: 1) To provide consultation on the
design and implementation of human subjects research in the areas of diabetes, obesity and
metabolism; 2) To provide specialized technical services for clinical investigation in diabetes,
obesity and metabolism; and 3) To provide expertise and training in diabetes-specific
research methodology.